A BCR transgenic mouse model to study glycan-specific B cells

SUMMARY
Tumor associated carbohydrate antigens (TACAs) are aberrant glycosylation products that are expressed on
cancer cells but absent on most normal cells. Their expression is typically associated with metastasis, poor
prognosis, and reduced overall survival. Our understanding of the mechanisms regulating antibody responses
to TACAs is very limited. To overcome the limitations associated with studying the rare B cells that give rise to
these responses, we generated a mouse in which the rearranged heavy chain variable region from a tumor
glycan-reactive antibody was knocked into the endogenous heavy chain locus. We propose to characterize this
mouse model by determining the potential for transgenic B cells to carry out antibody-dependent versus
antibody-independent effector mechanisms in the productive anti-tumor response (Aim 1) and identify conditions
which stimulate transgenic B cells to undergo isotype switching and differentiation to plasma cells (Aim 2). The
findings emanating from these studies are expected to reveal novel strategies to harness the anti-tumor potential
of B cells with specificities for cancer-expressed glycans.

Public health relevance
NARRATIVE This project will assess the protective role that B lymphocytes and their antibody products play in the anti- tumor immune response. Completion of this project is expected to lead to effective novel treatments for cancers.